Accelerating microbiota recovery to protect against Clostridioides difficile

Project summary
Opportunistic Clostridioides difficile (previously Clostridium difficile) infection is a significant public health threat,
primarily affecting hospitalized patients and leading to severe, life-threatening diarrhea. The CDC classifies C.
difficile infection as an urgent health threat due to its high incidence, morbidity, and mortality rates. The infection
typically follows antibiotic therapy (i.e., treatment with 3rd generation cephalosporins, fluoroquinolones, and
clindamycin), which disrupts colonization resistance mediated by the normal colonic microbiota, allowing C.
difficile to colonize the gastrointestinal tract and begin producing toxins to trigger antibiotic-associated colitis.
Our long-term research goal is to understand how colonization resistance can be strengthened to prevent C.
difficile infection. Our central hypothesis is that restoring epithelial hypoxia after antibiotic treatment can
accelerate microbiota recovery to restore colonization resistance against C. difficile. We will test our hypothesis
using the following specific aims: (i) determine whether treatment with a second-generation probiotic,
Anaerostipes caccae, can accelerate microbiota recovery after antibiotic treatment to restore colonization
resistance against C. difficile, and (ii) determine whether pharmacological activation of epithelial peroxisome
proliferator–activated receptor gamma signaling can accelerate microbiota recovery to restore colonization
resistance against C. difficile. The proposed experiments provide innovation by establishing a proof of concept
for a completely new and original starting point for preventing C. difficile infection. This outcome will be significant
by providing mechanistic insights into colonization resistance against an important opportunistic pathogen, which
will be of wide appeal among researchers interested in antimicrobial-resistant infections, microbiota research,
and intestinal biology.

Public health relevance
Project Narrative Our research seeks to explore innovative approaches to prevent Clostridioides difficile infection by accelerating microbiota recovery after antibiotic treatment. We hypothesize that restoring epithelial hypoxia using a second- generation probiotic or pharmacological activation of PPAR-γ signaling can strengthen colonization resistance. The outcomes of this study will provide new insights into microbial and host interactions, contributing to novel strategies for preventing opportunistic infections in vulnerable patients.